Interdisciplinary Nutrition Sciences Symposium: Obesity and the Brain Across the Life Course

PROJECT SUMMARY/ABSTRACT
We will convene the 4th annual Interdisciplinary Nutrition Sciences Symposium (INSS), entitled “Obesity and the
Brain Across the Life Course.” This conference will address the critical need to establish rigorous interdisciplinary
and translational approaches in the context of nutrition and obesity to effectively prevent and treat a variety of
physiological outcomes as they relate to aging and the brain. Interactive discussions will enable early career
investigators and faculty, including those underrepresented in science, to engage with senior investigators.
These valuable experiences will provide early career investigators and trainees with a foundation upon which
they will be able to contribute to the next generation of successful aging, obesity, and brain research. Confirmed
and invited speakers will include leading national academic scientists from diverse backgrounds with expertise
in aging biology, translational obesity, and nutrition/diet research. The five interactive sessions are organized to
facilitate and encourage integration across disciplines, synthesize knowledge, and generate new ideas in
selected areas of aging, obesity, and brain research. A major goal of the conference is to build upon the dialogue
in our previous successful symposia to develop best practices for translational and mechanistic science and to
generate ideas for proposals and collaborative projects. We will feature a networking lunch to encourage
discussion across scientific approaches, seniority, and industry/academia relationships. We will also hold an
early career lunch and workshop to allow opportunities for detailed discussions around mentoring and career
development. Rigorous evaluation of the symposium will involve summative assessment activities through online
surveys conducted via the conference website to assess what participants learned, what was effective, and what
needs improvement. An anticipated deliverable of INSS 2023 is a scientific paper geared towards a major aging
journal on how to translate findings from basic and clinical studies toward improving cognitive outcomes in aged
adults with obesity based on rigorous evidence. We will promote the symposium broadly via national societies,
including The American Geriatrics Society, The Gerontological Society of America, Obesity Medicine
Association, American Society for Nutrition, The Obesity Society, Translational Geroscience Network.
Additionally, the symposium will be promoted through the University of North Carolina Center for Aging and
Health networks, and NIH-funded centers such as the Nutrition Obesity Research Centers, Alzheimer’s Disease
Research Centers, and others. We anticipate that attendees will span the diverse fields of gerontology, geriatrics,
cognition, physiology, biochemistry, nutrition, and more. We anticipate attendance of approximately 100
scientists, based on the success of the prior three symposia and the outstanding leading keynote speakers who
have agreed to attend.

Public health relevance
PROJECT NARRATIVE We propose to convene the 4th annual Interdisciplinary Nutrition Sciences Symposium, entitled “Obesity and the Brain Across the Life Course,” to address the critical need to establish rigorous interdisciplinary and translational approaches in the context of nutrition and obesity to effectively prevent and treat a variety of physiological outcomes as they relate to aging and the brain. The goal of the symposium is to generate ideas for proposals and collaborative projects and to develop best practices for mechanistic and translational studies at the crossroads of cutting-edge aging, obesity, and brain research.